2007 CARTILAGE BIOLOGY & PATHOLOGY GORDON RESEARCH CONFERENCE

Worldwide increasing interest and the fascination which cartilage research is receiving today has to do with the two faces of cartilage: On the one hand, cartilage is a permanent tissue of outstanding biomechanical properties in the adult organism, providing joints with elasticity and high mechanical stability and ensuring mobility. On the other hand, cartilage has evolved in evolution as a transient tissue, shaping a model of the skeleton. Osteoarthritis (OA) and other degenerative joint diseases are not an inevitable fate coming with age. Several decades of research have shown ample evidence for genetic predisposition and for environmental or occupational risk for developing osteoarthritis. Nevertheless, there is still insufficient progress in understanding the pathogenesis of OA, including mechanisms of cartilage destruction and joint remodeling. As a result, there is only slow progress in the development of medication for prevention, therapy and diagnosis of OA in early phases, leaving joint replacement operations as the final therapy in late stages. With the recognition that degeneration and remodeling events in OA cartilage reflect changes in differentiation, gene expression and metabolic activities of the articular chondrocyte, the biology of this cell type has been moving to the center of research focus. Major progress in our understanding problems of cartilage degeneration, hypertrophy and remodeling in osteoarthritic joints has come from basic studies using tissue culture and transgenic animals. Strong evidence shows that the molecular mechanisms responsible for these events are very similar to mechanisms regulating chondrocyte differentiation, maturation and endochondral ossification in skeletal development This overlap of regulatory phenomena was a major rationale for the first two Gordon Conferences on cartilage biology. These two very successful conferences on cartilage biology brought together, for the first time, the fields of skeletal development, biochemistry, biomechanics, cell- and molecular biology of cartilage with the fields of cartilage pathology, human genetics of skeletal disorders, orthopedic research and tissue engineering. In setting up the program for the third conference, special attention is being paid to offer young scientists and minorities the chance to present and discuss their new data. But it was also felt that the conference would not be successful without the seminal and highly motivating contributions of the leading senior scientists in this field who had been instrumental in shaping the format and scientific level of the previous conferences. Special attention has been given to assure that the meeting takes full advantage of substantial representation of woman scientists as speakers and session chairs.